Eukaryotic Completion of DNA Replication

Project Summary
The mechanism by which cells recognize and complete replicated regions at their precise
doubling point must be remarkably efficient, occurring thousands of times per cell division along
the chromosomes of humans, and is a fundamental step required for genomic stability in all cells.
Yet until recently, the question of how this process occurs had not been characterized, in any cell
type. We recently demonstrated that the completion of DNA replication in E. coli involves an
enzymatic system that effectively limits cellular replication when it reaches its `doubling point'
by allowing converging replication forks to transiently pass each other before the excess, over-
replicated regions are incised, resected, and joined. The completion reaction requires RecBCD
and involves several proteins associated with repairing double-strand breaks including, SbcC-
SbcD-ExoI. However, unlike double-strand break repair, completion occurs independently of
homologous recombination and RecA.
Many of bacterial proteins required to complete DNA replication have clear homologs in
eukaryotes. Bacterial SbcC-SbcD and ExoI are highly conserved with Mre11-Rad50 and CtIP, a
poorly characterized nuclease complex essential for genome stability, normal development, and
viability in mammals. Here, we propose to extend these important findings to eukaryotic cells,
and to determine the enzymatic pathway that catalyzes the completion of replication in the model
eukaryote, Saccharomyces cerevisiae. We employ a novel approach that enables us to identify,
map, and characterize sites where replication completes directly on eukaryotic chromosomes.
We will use this approach to establish the essential role of Mre11-Rad50-CtIP during cellular
replication, determine the enzymes required for the eukaryotic completion reaction, and identify
synthetic lethal genes in completion mutants, that can be targeted for potential therapeutics. The
results of these studies will identify a fundamental, yet heretofore unstudied, aspect of cellular
replication that is central to genome stability.

Public health relevance
Project Narrative: The mechanism by which DNA replication completes is essential to genome stability, and is a driver of metastasis when mutated in cancers. We have identified genes that are synthetic lethal for bacteria mutated in completing replication. Therefore, extending these results to characterize the mechanism by which DNA replication completes in eukaryotes will likely to identify novel genes that can be targeted for cancer therapeutics.